Pharmacological chaperones for the treatment of Open-Angle Glaucoma

Open-angle glaucoma is the second leading cause of blindness worldwide, affecting nearly 70 million individuals. Nonsynonymous mutations in the myocilin gene lead to the most common hereditary form of open-angle glaucoma and account for 3-4% of all cases. Disease-causing mutations, localized to its olfactomedin domain (mOLF), destabilize the myocilin protein, leading to its misfolding and accumulation in the endoplasmic reticulum of trabecular meshwork cells, thereby activating a cellular stress response that ultimately results in cell death and disease progression. Pharmacological chaperones are small molecules that bind to proteins and stabilize their native conformation, preventing aggregation or aberrant behavior of the protein, and thereby correcting disease. In this proposal, we outline a strategy to identify a pharmacological chaperone that binds to myocilin protein, stabilizing it, preventing the death of trabecular meshwork cells, and halting disease progression. In contrast to current therapies which target secondary symptoms such as intraocular pressure, our approach represents the first treatment for open- angle glaucoma that corrects the fundamental cause of disease. Aim 1 ? Execute a fragment-based NMR screen to identify small molecule mOLF binders and characterize their binding modes using X-ray crystallography. Aim 2 ?Synthesize or purchase elaborated hit fragments to generate a focused library of mOLF pharmacological chaperones. Aim 3 ? Screen and select the focused library using in vitro assays to define SAR of elaborated hit fragments. Our expected outcomes are 2-3 lead molecules that meet our defined potency targets and are suitable starting points for a robust lead-optimization campaign to identify a clinical candidate for development. Such a campaign would involve increased medicinal chemistry resources, in vitro PK and ADME characterization, and pharmacology studies in a mouse model of myocilin-linked glaucoma; this work would constitute a STTR Phase II program.

Public health relevance
RELEVANCE TO PUBLIC HEALTH. Open-angle glaucoma is the second leading cause of blindness worldwide, affecting nearly 70 million people globally, including 3 million in the United States. This proposal details our plan to develop the first therapeutic that corrects a causative mechanism of open-angle glaucoma.